Matching Treatments to Cognitive Deficits in Offenders with Substance Use Disorders

Project Summary/Abstract
Prior research has identified two subtypes of antisocial offenders, typified by distinct dysfunctional cognitive-
emotion interactions undermining self-regulation. One subtype is characterized by an attention-based
abnormality, which impairs adaptive processing of contextual information, tangential to one’s primary focus. This
abnormality is typified by offenders with high levels of callous/unemotional traits. A second subtype is
characterized by hyper-reactions to personally relevant cues, interfering with executive functions that are
otherwise needed to regulate behavior. This abnormality is prevalent in those with high externalizing
characteristics. Our team has developed cognitive skills training that addresses each of these specific deficits in
distinct ways. These distinct interventions are intended to address mechanism-specific cognitive emotional
dysfunction, as opposed to treating distinct dysfunctions with a uniform approach. Under an R21, our pilot work
has shown evidence of improving outcomes in offenders by matching specific deficits with focused skills training.
Here we seek to conduct a well-powered, randomized clinical trial to demonstrate reliability and generalizability
of these effects. We expect to verify prior findings of improved outcomes by matching individual deficits with the
targeted interventions. We will examine effects of treatment on specific cognitive skills (assessed by laboratory-
based tests) and real-world behavioral outcomes including substance use behaviors, institutional adjustment,
and recidivism following release from prison. Further, we will examine advanced neuroimaging measures to
assess brain changes with treatment. This will aid in specifying potentially different mechanisms of treatment
success in each respective group. This project addresses the ongoing need to improve and validate focused
interventions that target specific deficits, replacing less-effective one-size-fits-all approaches.

Public health relevance
Project Narrative Research has shown that dysfunctional cognitive-emotion interactions undermine self-regulation in subtypes of high-risk individuals which contribute to risk for relapse to substance use and antisocial activity. Here we implement a randomized clinical trial of two cognitive remediation training programs to address these deficits and track real-world behavioral and neural change associated with these interventions.